Unmet needs for specific subsets of EGFR mutated lung cancer

ABSTRACT/PROJECT SUMMARY
Lung cancer is the leading cause of cancer-related mortality for both men and women in the United States. The
number of new cases of lung cancer exceeds 220,000 yearly; with an appalling five year survival of 16% for
non-small-cell lung cancer (NSCLC). The overall goal of the proposed research is to decrease suffering and
improve survival for NSCLCs harboring epidermal growth factor receptor (EGFR, ErbB1) or ERBB2 mutations
(i.e., >20% of all NSCLCs; the most common cause of cancer death worldwide). EGFR mutated NSCLCs
comprise diseases with a distinct biology marked predominantly by targetable mutations involving inframe
indels in exon 19 and the point mutation L858R. Some tyrosine kinase inhibitors (TKIs) can effectively inhibit
signaling from these aberrant kinases, disrupt their downstream signaling cascades and induce apoptosis.
TKIs are now clinically available (gefitinib, erlotinib, afatinib and osimertinib) or in development as palliative
therapies for advanced EGFR mutated NSCLC. However, the third most prevalent group of EGFR mutations in
NSCLC (>10% of cases) is composed of inframe insertions (of 1-4 amino-acids spanning residues E762 to
C775) within exon 20 of EGFR that are insensitive to approved EGFR TKIs. Therefore, the identification of
therapies that can or not abrogate kinase activity for EGFR exon 20 insertion mutated NSCLCs are essential to
understand the promises plus limitations of precisions therapies for this cohort of tumors. The close homology
of EGFR and ErbB2 insertion mutations highlights that future therapeutic options for EGFR exon 20 insertion
mutations will be applicable to other cohorts of NSCLC. The proposal will take advantage of our budding
comprehensive models to completely characterize EGFR exon 20 mutants and identify novel therapies for this
genomic subgroup of tumors. Aim 1 will establish robust preclinical models to represent EGFR exon 20
insertion mutations as a homogenous group; with a goal of generating novel models that are necessary to
evaluate therapies against these NSCLCs. Aim 2 will evaluate available and novel therapies against EGFR
exon 20 mutants; with a goal of identifying effective therapies - including EGFR/ERBB2 exon 20 mutant
specific TKIs – and their putative mechanisms of resistance. Aim 3 will support the clinical development of an
EGFR/ERBB2 exon 20 mutant specific TKI; with a goal of confirming the clinical efficacy of such a class of
drugs and designing rational combination therapies to prevent the development of acquired resistance. The
final translational goals of these models are to provide rational concepts that can be explored initially in
confirmatory clinical trials and subsequently in the clinical care of patients. If these goals are met, quality of life
and survival of patients will be extended beyond what is currently available.

Public health relevance
PROJECT NARRATIVE/SUMMARY STATEMENT Lung cancers harboring ErbB mutations are significant causes of morbidity and mortality (>35,000 deaths yearly) in the United States; comprising a distinct collection of malignancies defined by driver oncogenes addicted to their signaling cascades. This concept has translated rapidly into one of the most effective class of palliative therapies for NSCLCs: genotype-matched precision kinase inhibitors. The identification of novel inhibitors and/or combination therapies for EGFR exon 20 insertions is essential to understand the promises plus limitations of precision treatments for in this important patient cohort.